Mouse Phenotyping

The Mouse Phenotyping Shared Resource (MPSR) was established in 2001 to provide expert, readily available, and affordable experimental pathology support to OSUCCC investigators utilizing animal models of human cancer. The MPSR specializes in the morphologic characterization of newly produced lines of genetically engineered mice, but also provides a variety of other customized pathology services, including necropsy, slide preparation, semi-quantitative histopathology for experimental studies, morphometry, hematology, clinical chemistry, consultation and referral. The MPSR is headed by Donna F. Kusewitt, D.V.M., Ph.D., a board-certified veterinary pathologist and NCI-funded Investigator and staffed by Deborah Devor Henneman, B.S., each with more than 20 years of experience in carcinogenesis and experimental pathology. The MPSR is strongly supported through the excellent veterinary resources (clinical pathology, histology, and immunohistochemistry service) and veterinary pathology expertise (10 board-certified veterinary pathologists) available in the Department of Veterinary Biosciences (VBS) at The Ohio State University (OSU). Since its inception in 2001, the MPSR has provided high quality experimental pathology services tailored to meet the needs of the growing number of OSUCCC investigators who employ animal models of human cancer. During this time, 23 funded CCC members consulted on 38 projects requiring 1,042 hours of MPSR service, representing 75% of its entire workload. The MPSR has also provided requisite information for grant applications and manuscripts for many of OSUCCC members. The volume of work performed in the MPSR has steadily increased since the service was initiated and, given the projected expansion of OSUCCC research programs, a continued increase in MPSR usage is anticipated. Indeed we provide documentation of 37 CCSG-funded investigators with over 40 projects requiring MPSR support in the near future. Finally, the MPSR also serves as an essential venue for training future mouse pathobiologists as part of an NCRRfunded T-32 training grant, "Mouse Pathobiology: Models of Human Disease".